North Texas ADRC - Research Education Component

The Research Education Component (REC) of the North Texas Alzheimer's Disease Research Center (NT-
ADRC) aims to develop and enhance research educational and training activities in support of future
generations of the research workforce to address the national need for high quality investigators engaged in
transformative and multidisciplinary research. The REC focuses on enrolling and developing early-stage
investigators from diverse backgrounds in its training programs, promote their career and support their growth
towards independence. The REC activities and programs are geared towards meeting the overall goal of the
NT-ADRC of examining the role of hypertension and other cardiometabolic factors and underlying molecular
mechanisms in the pre- and early symptomatic phases of AD/ADRD, developing innovative biomarkers for
these stages and identifying potential therapeutic targets. We are leveraging an extremely robust set of local
research educational resources spanning strong neuroscience and world renown cardiovascular research
programs, unique strengths in biomedical engineering, data sciences, and informatics, state-of-the-art
neuroimaging, and successful clinical and translational research in AD therapeutics at UT Southwestern and
our member institutions. The REC will serve as a training hub by interacting with the other cores and link with
the National REC resources to provide outstanding AD research training. The REC curriculum includes a set of
activities developed by the Center in addition to resources leveraged by the institution or training partners and
collaborators. REC Scholars will be enrolled for 1-2 years. Their REC program includes mentoring as well as a
combination of experiential and synchronous and asynchronous educational activities. We identify the REC
Scholars from multiple training programs (Behavioral Neurology, Neuropsychiatry, Cardiology, Hypertension,
Neuropathology, Clinical Informatics and Geriatrics fellowships), and Doctorate programs (Neuropsychology,
Neuroscience, Social Work, and Biomedical Engineering). The NT-ADRC REC program is designed to mentor
new or early-stage investigators to advance towards independence in AD/ADRD research, particularly
investigators/trainees from under-represented groups. The REC Leaders in conjunction with the REC
committee members who possess diverse skills and backgrounds will oversee the activities of the REC,
address barriers to success, and evaluate the Scholars to ensure they accomplish their career goals and the
program to ensure it accomplishes its overall mission.